DE NOVO HYPERTENSION AFTER CARDIAC TRANSPLANTATION

The purpose of this study is to increase our understanding of post transplantation hypertension. Favorable results from this study may help to correct hypertension experienced by organ recipients.